High-flow portable oxygen concentrator for long-term oxygen therapy

Summary/Abstract: Long-term oxygen therapy (LTOT) is an established treatment for 1.5 million Americans
with chronic lung diseases such as chronic obstructive pulmonary disease, interstitial lung disease, and
pulmonary hypertension. These patients often rely on oxygen (O2) concentrators. Current state-of-the-art
stand-alone O2 concentrators work by drawing in ambient air and filtering out most of the nitrogen—thereby
producing concentrated oxygen (85-92% purity) for the patient. Portable oxygen concentrators (POCs) are
smaller/lighter units that are battery-powered, lower-flow versions that permit LTOT patients to be mobile.
Unfortunately, existing commercial POC options result in significant customer dissatisfaction because of
inadequate oxygen flow, excess weight, inadequate battery life, and noisy operation. For many POC users, the
limited flow rate and low oxygen concentration fail to meet the minimum specifications of their prescription—
leaving them dependent upon and tethered to stationary in-home oxygen units or O2 tanks. Equally
unfortunate is the fact that the underlying technology for these commercial POCs is maxed out and stagnant—
having gone mostly unchanged for decades. To address these serious drawbacks, Pranions, Inc. is developing
a next-generation, high-flow-rate, low-weight POC designed to generate 100% pure oxygen from ambient air
as the input. The proprietary basis for this advance is an entirely novel hybrid approach to its physics of
operation via an electrochemical core. As envisioned, it will offer higher oxygen flow rates, 100% oxygen purity,
quieter operation, and longer duration on full battery charge while being light enough for true portability. In
preliminary studies completed by the Pranions R&D team, proof of concept of the device has been established
via an initial prototype oxygen-concentrator unit. Consequently, Pranions is proposing a Direct-to-Phase II
(D2P2) SBIR project to pursue the key next steps in their POC development and to accelerate their effort to
address the needs of millions of LTOT patients—including many who are currently underserved. To move this
technology rapidly toward commercial deployment, the expert interdisciplinary Pranions R&D team will pursue
three specific aims for the D2P2 work: 1) Scale up the proof-of-concept preliminary electrochemical core; 2)
Build a fully functional POC prototype and validate performance metrics against a market control device; and
3) Test prototype for safety re: biocompatibility, electrical, and chemical safety per FDA guidance. This SBIR
data obtained will position Pranions for engagement with the private sector for follow-on development, early
feasibility studies in human subjects, regulatory approvals, and commercial deployment into what is expected
to grow into a $6B POC market globally. Pranions anticipates being able to significantly penetrate this market
with its next-generation, cost-competitive POC technology, and to thereby enable substantial improvements in
the health, mobility, and quality of life for millions of LTOT patients in the U.S. and worldwide.

Public health relevance
For the ~1.5 million patients in the U.S. alone who require long-term oxygen therapy (LTOT) for their survival, Pranions is developing a next-generation portable oxygen concentrator (POC) designed to significantly improve the healthcare and quality of life for those patients. As envisioned, this innovative, proprietary POC unit make use of the same ambient air that current commercial POC units use but will eliminate the current drawbacks of low oxygen levels, low flow rates, excess weight, high noise levels, and inadequate battery life. This novel, cost-competitive POC unit—once commercially deployed—will address a significant portion of what is expected to become a $6B POC market globally and will thereby enable substantial improvements in the health, mobility, and quality of life for millions of LTOT patients.